Neurobehavioral Impacts of Medical Cannabis Use: An Observational Study

Project Summary
This R01 proposal is submitted in response to NOT-DA-22-003, Public Health Research on Cannabis. The
overarching aim is to assess cognition, neural function, and SUD risk in a sample of patients treated with medical
cannabis products in Minnesota (n=120) as compared to non-cannabis using controls (n=60) and to differentiate
outcomes based on prescribed doses and blood concentrations of THC versus CBD as an objective measure of
drug exposure. Patients will be aged 35-65 and qualified for medicinal cannabis treatment in Minnesota due to
diagnoses of chronic pain. While deficits in learning, memory and executive functions are reliably observed in
young adult recreational cannabis users, it is unclear whether similar impairments characterize individuals who
use cannabis for medical reasons, whether adults may be uniquely vulnerable to cannabis-related impairments
or if, in fact, use in this age group might be neuroprotective. There are very few published studies of medical
cannabis users that comprehensively focus on neurobehavioral outcomes even though at least 5 million people
are registered for medical cannabis treatment in the United States. The current study will address this gap
through a pre-post assessment of users as compared to matched controls (pain patients who do not use
cannabis). Participants will be recruited through posted advertisements and through dispensaries via a
collaboration with the primary local supplier of medical cannabis. They will complete a comprehensive pre-
treatment behavioral assessment as well as multimodal MRI assessments. Sequences from the HCP-Aging
battery will be utilized. All measures will be repeated after four months of treatment. Participants will be
interviewed monthly by phone in the interval between visits. Behavioral outcomes, including substance misuse,
will be measured. Blood cannabinoid levels will be quantified and correlated with behavioral and neural
outcomes. Our three aims are (1) To assess impacts of medical cannabis compounds on cognition and behavior
in otherwise cannabis-naive adults to determine whether impairments that characterize younger users are
evident after the onset of medical cannabis use; we will also measure treatment-related changes in pain using
well-validated measures. (2) To similarly assess the impacts of medical cannabis compounds on white matter
microstructure, functional brain activity and functional connectivity using diffusion-weighted scans, task-based
fMRI, and measures of resting state connectivity; (3) To differential change over time in these outcomes as a
function of (a) exposure to distinct cannabinoids (THC vs. CBD) as assessed through blood concentrations and
(b) age. Sex as a biological variable will be assessed as a covariate of interest. Thus, this proposal will yield a
rich dataset through which medical cannabis effects on adults’ neurobehavioral function can be assessed and
contrasted with the literature on non-medical users.

Public health relevance
Project Narrative Despite millions of active prescriptions for medical cannabis in the United States, relatively little is known about impacts on behavior, neural function, and pharmacology. This project measures neurobehavioral function and drug exposure with an emphasis on learning, memory, and executive functions at two timepoints, pre- treatment and four months post-treatment initiation, in adult-onset medical cannabis users who are prescribed cannabis products for the treatment of chronic pain. Behavioral and neuroimaging findings, as well as assessments of efficacy, are expected to inform public health and policy-based initiatives regarding impacts of THC- versus CBD-dominant forms of cannabis in adult initiates who are otherwise cannabis naive.